Patient Navigation in Gynecologic Oncology: Improving Care among Rural Endometrial Cancer Patients

PROJECT SUMMARY
Rural residents with endometrial cancer (EC), the most prevalent gynecologic cancer in the US, have 8-
17% higher odds of mortality than their urban counterparts. As the number of new EC cases is expected to
increase 50% by 2030, this urban-rural disparity is expected to continue widening. Contributing to this disparity
is the reduced receipt of guideline-concordant treatment; in particular, rural patients with EC are less likely to
receive comprehensive surgical care, the cornerstone of regional stage EC treatment.
The overall objective of this project is to identify and target multilevel barriers to receiving guideline-
concordant treatment among rural EC patients by developing and piloting a patient navigation intervention.
Patient navigation interventions can address a multitude of barriers faced by medically underserved cancer
patients and have been shown to shorten time to initiating treatment, increase receipt of and adherence to
treatment, and improve patient satisfaction. However, because of the substantial variation in the design and
delivery of patient navigation interventions, developing effective and cost-effective interventions for new
contexts and populations has become a major challenge; among treatment-related patient navigation
interventions, most have focused on patients with breast and colorectal cancers. Unlike these cancer patients,
EC patients have different needs, such as requiring treatment to be directed by a gynecologic oncologist, who
often are only located near urban areas or at academic medical centers. Only 10% of gynecologic oncologists
practice in rural areas, and as a result, rural EC patients often travel far distances for care. In the proposed
study, I will identify multilevel barriers to receiving guideline-concordant treatment among rural women with EC
(Aim 1), use intervention mapping to design a patient navigation intervention (Aim 2), and pilot a patient
navigation intervention (Aim 3). Using intervention mapping to design an EC navigation intervention will not
only precisely target the multilevel barriers to treatment but also will optimize the fit and implementation of the
navigation program within the gynecologic oncology setting. This approach is novel in that it integrates the
identification of appropriate implementation strategies into the program’s design.
This project will provide preliminary data for an R01 application to test the developed patient navigation
intervention in a Type 1, hybrid effectiveness-implementation trial. The expected outcomes of this study will
contribute to the National Institute on Minority Health and Health Disparities’ mission of using interventions to
eliminate health disparities among medically underserved populations. Additionally, I will receive training in (1)
community-engaged research methods to understand the multi-level determinants of cancer care equity, (2)
designing interventions to fit specific populations and context, and (3) conducting intervention studies. This
project will contribute to my long-term goal of becoming an independent investigator who develops and
evaluates interventions to reduce disparities in cancer care and outcomes among underserved populations.

Public health relevance
PROJECT NARRATIVE This project will provide the preliminary data for an R01 application to test an endometrial cancer navigation intervention against usual care using a Type 1, hybrid effectiveness-implementation design. Findings from this future R01 research will contribute to reducing disparities in the treatment and outcomes of rural endometrial cancer patients. Additionally, the current proposal will provide a model for how to effectively design implementation-ready, pragmatic patient navigation interventions to reduce disparities among other medically underserved patient populations.